Project 1: Establishing a robust functional cure

PROJECT SUMMARY (Project 1 – Robust functional cures with AAV-expressed eCD4-Ig)
eCD4-Ig is a potent and exceptionally broad fusion of the first two domains of CD4 to an antibody Fc
domain and a short tyrosine-sulfated coreceptor-mimetic peptide. In rhesus macaques, adeno-associated
virus (AAV)-expressed eCD4-Ig mediates consistent and very effective protection against SHIV-AD8 and
SIVmac239. eCD4-Ig also has properties that make it especially useful for establishing a functional cure in
rhesus macaques and perhaps in humans. These include its potency, breadth, difficulty-of-escape, low
immunogenicity when expressed by AAV, consistent expression by AAV, potent intrinsic ADCC activity, and
collaboration with serum antibodies to mediate ADCC. These properties allow eCD4-Ig to circumvent two
major problems associated with using AAV-expressed antibodies to establish functional cures, namely
immune clearance and viral escape. In preliminary data we show that AAV-expressed eCD4-Ig can
suppress replication of SHIV-AD8 for more than a year in 5 of 6 macaques. However we also show that,
when compared to the “Monkey monkey” described in Project 2, this suppression was less robust, meaning
that consistent ‘blipping’ of virus was observed in most eCD4-Ig-suppressed animals. Because the Miami
monkey expresses roughly 10 times the amount of total antibody observed in these eCD4-Ig-expressing
macaques, we hypothesize that greater expression of eCD4-Ig will result in more robust functional cures.
The goals of this project are thus to increase AAV-mediated expression of eCD4-Ig, to establish robust
functional cures in SHIV-AD8 and SIVmac239-infected macaques, to amplify the ADCC activities in these
macaques by stimulating host antibody responses to epitopes unmasked by eCD4-Ig, to establish a
consistent platform that will allow for evaluation of latency reversing agents, and to ask whether long-term
expression of eCD4-Ig by itself can impact the viral reservoir. These studies will improve and help
understand a viable approach to establishing similar functional cures in humans.